Animal care: supporting research on autoimmune, inflammatory and muscle diseases

The LACU assists the NIAMS IRP investigators with their research involving animals. NIAMS animals are housed in animal facilities located on the NIH campus, including the NIAMS LACU facility located in Building 10, room 9C127 (the Ambulatory Care Research Facility (ACRF)), as well as in Buildings 6B, 10A, 50 and Building 14. NIAMS animal users work primarily with mice and rats.

The NIAMS IRP Animal Program has oversight for 22 Animal Study Proposals (ASPs) using mouse and rat models. The LACU assists researchers with preparing ASPs through a thorough peer-review process and has three members (two voting and one alternate) on the NIAMS Animal Care and Use Committee (ACUC). The LACU maintains a near real time, detailed animal inventory, the foster colony, a large breeding colony, and the sentinel program for the IRP animals. A 1-hour training program, administered by the LACU colony manager, familiarizes all new NIAMS principal investigators with NIH and NIAMS-specific guidelines, a general overview of rodent colony management, and rodent biology as it relates to breeding and research guidelines. IRP project areas include arthritis, allergic rhinitis and other receptor-induced cellular responses, recombination/chromatin remodeling using activation-induced cytidine deaminase (AID) transgenic mice, familial Mediterranean fever (FMF), and tumor necrosis factor receptor-associated periodic syndrome. Additional research involves muscle and related diseases (experimentation with N-RAP protein, glycogen storage disease Type II, SIRT1 gene, myofibril assembly, and myositis) including sub-cellular organelles and cytoskeleton in skeletal muscle. Animals are used for in vitro experiments examining retroviral transduction, bone marrow transplantation, and epidermal differentiation using fetal and adult skin tissues. Many of the institutes studies involve apoptosis and autoimmunity, as well as cartilage studies focused on tissue-engineered cartilage, chondrogenesis, Growth Differentiation Factor-5, Cartilage Oligomeric Matrix Protein, and osteoarthritis.

The NIAMS program continues to meet all accreditation requirements set forth by Association for Assessment and Accreditation of Laboratory Animal Care International (AAALAC), including the most recent successful NIH-wide visit in June of 2021.